An intravaginal, wearable device for treating women with pelvic floor myofascial pain

Abstract
High tone pelvic floor dysfunction (HTPFD) is a major contributor to chronic pelvic pain, affecting up to 15%
of women in the United States. Intravaginal Electrical Stimulation (IES) and focal muscle vibration (FMV) can
play pivotal roles in managing muscle pain through distinct mechanisms. IES involves applying low-level
electrical currents to stimulate nerves, which can reduce pain perception by disrupting pain signals' transmission
to the brain and promotes the release of endorphins, providing short-term relief for muscle discomfort. FMV
employs mechanical oscillations to target muscle fibers, enhancing blood flow and relaxing muscle tension. This
process can alleviate muscle soreness and aid in recovery after exercise, making it effective in both pain
management and performance enhancement. By combining the benefits of IES and vibration in a wearable,
intravaginal device for women with HTPFD, individuals with muscle pain can discreetly access a multifaceted
approach that addresses pain perception, circulation, and muscle relaxation for pain relief. Bold Type proposes
development of an intravaginal, wearable device called “Violet” to provide pelvic floor muscle vibration
and electrical nerve stimulation therapy for patients with HTPFD on an “as needed” basis throughout
the day.
Bold Type specializes in developing connected, wireless medical devices. Our team has decades of product
development experience with expertise in medical devices, quality, and regulatory affairs. We have developed
proprietary hardware and software development kits that allow us to design and implement medical devices
efficiently by leveraging reusable subsystems that are designed and documented to comply with FDA
regulations. Building off these resources we propose the following Specific Aims: 1) Develop the Violet Device
to: (1) provide on-demand intravaginal electrical stimulation (IES) and vibration therapy to provide pain relief,
and (2) measure and track intravaginal temperature, motion, and position; 2) Develop the Violet software (mobile
app and embedded software) to track symptoms, wirelessly control the device, and extract data; and 3) Perform
formative usability and preliminary validation testing on a group of 15 healthy women.
Completion of these three aims will preliminarily confirm the following: (1) that patients can insert, retain, and
remove the Violet device without unacceptable discomfort; (2) that patients can feel the IES and vibration
stimulation and adjust their settings; and (3) that the system can accurately measure temperature, motion, and
body position and transfer data to a mobile device. Successful completion of these aims will prepare the way for
a Phase 2 project where a commercial grade system will be developed under FDA design controls and validated
in a longitudinal study to evaluate efficacy and achieve FDA clearance.

Public health relevance
1 Narrative 2 Bold Type’s Violet system offers chronic pelvic pain (CPP) and high tone pelvic floor dysfunction (HTPFD) 3 patients a critically needed, wearable, controllable device optimized for the relaxation and myofascial release of 4 muscles throughout the day. Our novel CPP solution will aid the growth of the United States economy by 5 contributing the Violet system to the medical device market, thus increasing the market size, and creating jobs 6 associated with the production, shipping, and sales of Violet devices. Bold Type’s wearable device for on- 7 demand therapy throughout the day will also enhance the quality of life of CPP and HTPFD patients by providing 8 pain relief when and where it is most needed in a discreet, convenient way.